Delaware Clinical and Translational Research ACCEL Program (TEVAL Core)

ABSTRACT - Tracking & Evaluation (TEVAL)
The Tracking and Evaluation (TEVAL) Core of the Delaware ACCEL Clinical and Translational Research
Program (ACCEL-CTR) will facilitate and assess the success of building a sustainable clinical and translational
research infrastructure in Delaware. During ACCEL3, the priorities of TEVAL will move beyond defining metrics
and accounting for research productivity, which has been a high priority over the past nine years, and transition
to a greater focus on summative evaluation, reflective of the maturity of the ACCEL-CTR. The Specific Aims of
TEVAL are 1) Monitor and track metrics and key performance indicators of success; 2) Provide evaluation
support to CTR and Core leadership to facilitate continuous improvement; 3) Assess the impact of the ACCEL-
CTR utilizing multi-level impact studies, focusing on the individual, institutional, infrastructure, and community
health levels; and 4) Share best practices in evaluation and clinical and translational research within and
beyond Delaware. We will provide CTR and Core leadership with the information necessary to support data-
driven decision-making and to facilitate continuous improvement. TEVAL will examine how the ACCEL-CTR
has impacted investigator research capacity, research infrastructure, research collaborations, investments in
research addressing health equity and the health needs of Delawareans, as well as the translational impact of
funded projects in accordance with overall project aims. We will share best practices and lessons learned
through evaluation briefs, presentations, infographics, and publications. In addition, the Delaware TEVAL Core
leads the National CTR Evaluator’s Network and together with other CTR evaluators will share best practices
in translational research evaluation. The work of TEVAL will be guided by the American Evaluation
Association’s Guiding Principles for Evaluators: systematic inquiry, competence, integrity, respect for people,
and common good and equity. The ACCEL-CTR evaluation will incorporate multiple approaches into its
participatory, theory-based evaluation, including a concentration on the intended use of data by intended users
(utilization-focused evaluation) and iterative, flexible methods to address innovation and system complexity
(developmental evaluation). In addition, our initial planning during which indicators were built into the program’s
theory (embedded evaluation) and our intentional focus on intermediate and long-term results towards meeting
ACCEL-CTR aims (results-based accountability) are intended to provide our stakeholders with the necessary
information for summative decision-making. These methods enable TEVAL to provide high quality, actionable
analyses and reporting to leadership on outcomes and impacts regarding enhancing infrastructure,
strengthening research, fostering collaborations, and improving health and health equity in Delaware.

Public health relevance
Project Narrative Please refer to the overall section.